PELVIC INFLAMMATORY DISEASE (PID) EVALUATION &CLINICAL HEALTH STUDY

This study is the first randomized, multi-center clinical trial to compare the efficacy of inpatient versus outpatient treatment of PID in preventing involuntary infertility. The study population will include non-pregnant women ages 14 years to 37 years with the recent diagnosis of PID. Patients will be randomized on the GCRC to begin outpatient oral antibiotic therapy or receive inpatient IV antibiotic therapy.